Sign Here: How to Conduct Informed Consent with Deaf Individuals

PROJECT SUMMARY/ABSTRACT
The U.S. Deaf community – a minority group of more than 500,000 people who use American Sign Language
(ASL) – is one of the most understudied and underserved populations within our nation’s healthcare system.
Reasons for this underrepresentation include lack of language access in healthcare and research settings, as
well as communal feelings of mistrust toward the medical community. For example, clinical researchers often
recruit, conduct informed consent, and collect data in spoken or written English, procedures that are
inaccessible to Deaf ASL users. Additionally, healthcare providers and clinical researchers follow a medical
model to “cure” or “fix” deafness, whereas most Deaf people do not want to be fixed, but rather to be respected
as a cultural and linguistic minority group.
To begin to rectify mistrust and underrepresentation in clinical research, the informed consent process has
been suggested as a key area of intervention. As such, our team developed a prototype intervention to train
research personnel to competently and sensitively interact with Deaf research participants during the informed
consent process. The intervention was designed through a two-year collaboration between UMass Medical
School (UMMS) and the local Deaf community – community forums, focus groups, and an intervention
development team inclusive of Deaf researchers, filmmakers, and laypeople. The resulting prototype
intervention – a 30-minute training film titled Sign Here: How to Conduct Informed Consent with Deaf Research
Participants – has not yet been refined based on critical input from the target audience (hearing clinical
research personnel); not been formally evaluated for efficacy; nor adapted to meet the needs of hearing
healthcare providers and medical/nursing students.
We, therefore, propose to conduct a series of focus groups with key stakeholders to refine, expand, and
finalize two distinct versions of the Sign Here training film – one for clinical researchers and one for healthcare
providers. After the final interventions are complete, we will conduct two concurrent pilot randomized controlled
trials (RCTs) to test the feasibility, acceptability, and preliminary efficacy of the two training interventions. 40
research personnel and 40 healthcare providers will be randomized to receive (1) the version of the Sign Here
training film tailored to their professional role or (2) an “intervention as usual” condition (i.e., standard NIH
guidance on how to communicate informed consent to Deaf or hard-of-hearing individuals).
Results will potentially validate products of immediate value – two highly-accessible, easy-to-disseminate
training films to promote the inclusion of Deaf individuals in our nation’s healthcare system and clinical
research endeavors. Results will also inform the design of a large, multi-institution study that will explore the
real-world scalability of the Sign Here training interventions in academic medical schools across the nation.
The long-term objectives of our research program are to increase the number of Deaf people engaged as
research participants, as well as increase the number of Deaf people engaged as research team members.

Public health relevance
PROJECT NARRATIVE The U.S. Deaf community – a minority group of more than 500,000 people who use American Sign Language (ASL) – is one of the most understudied and underserved populations within our nation’s healthcare system. Reasons for this underrepresentation include lack of language access and feelings of mistrust toward the medical community. We propose to refine and test two training interventions – one for healthcare providers and one for clinical researchers – that teach professionals how to skillfully and sensitively interact with Deaf individuals, especially during the informed consent process. Results will inform a large national study that will test the effectiveness of our training interventions in real-world academic and clinical settings with a range of available training resources.